NeuroImaging and Electrophysiological Facility

Project Summary/Abstract: NeuroImaging and Electrophysiology Facility (NIEF)
The COBRE Neuroimaging and Electrophysiology Facility (NIEF) has developed into a state-of-
the-art resource for the Center for Neuroplasticity investigators and the larger University of Puerto
Rico (UPR) biomedical research community. It has also successfully continued to strengthen the
research quality of all its users to facilitate a transition toward competitive federal funding. We
propose to further expand these efforts by making the NIEF a self-sustainable imaging and
electrophysiology instrumentation service facility with powerful data analysis software and new
equipment and upgrades to existing NIEF equipment in order to meet the needs of our growing
user-base. The first step (Specific Aim 1) will be to establish a web-based cloud data analysis
computing network available to UPR scientists located at all major sites/campuses currently
conducting neuroscience research. The NIEF will invest in new computers and software tools
necessary to provide onsite and remote data analysis services to all of its users. The second step
(Specific Aim 2) will be to continue upgrading and integrating imaging and electrophysiological
applications within existing NIEF instrumentation. The NIEF will provide existing and new users
the ability to combine electrophysiological recordings, optical modulation of action potentials and
genetic methods through the addition of two additional electrophysiology set-ups equipped for
performing optogenetics. This aim will be strengthen by a 20 million dollar investment by the UPR
in the renovation of 2 floors at the Molecular Sciences Research Center (MSRC) for the
establishment of a Neuroplasticity floor and a state-of-the-art animal facility. The third step
(Specific Aim 3) in the continued evolution of the NIEF will be to further increase the equipment
flexibility and detection sensitivity by purchasing a Super-Resolution/TIRF (total internal
fluorescent microscopy) microscopy system and the upgrading of one of our current confocal
systems with Super-Resolution/TIRF capabilities. Moreover, the addition of an
Electroencephalography (EEG) suite will allow users to detect changes in brain activity and
quantify how these changes relate to a wide range of neurocognitive phenomena. Also, the NIEF
will continue and further strengthen the training of current and next-generation UPR scientists
(Specific Aim 4) through our highly successful seminar and workshop series. Fulfillment of these
four aims will enable the COBRE NIEF to be a completely self-sustained neuroimaging research
facility and a role model for Puerto Rico and the Caribbean.